Spectroscopic and Mechanistic Characterization of Novel DNAzymes Selective for Redox-active Metal Ions

PROJECT SUMMARY/ABSTRACT
DNAzymes represent one of the most recent classes of diverse, catalytically active biomolecules. However,
despite their discovery >25 years ago and exceptional potential for broad analytical and therapeutic applications,
our understanding of metallo-DNAzymes in terms of binding selectivity, structure, and catalytic mechanism still
lags far behind that of metalloproteins. Although DNAzymes have already been developed as highly selective
metal ion sensors, the lack of fundamental knowledge regarding metallo-DNAzyme function has precluded the
application of rational design to enhance metal binding affinity and specificity. The goal of this project is to obtain
unparalleled insight into the structure-function relationships of metal-binding DNAzymes specific for redox-active
metal ions (RAMIs) with high physiological relevance (e.g., Fe2+, Fe2+, Cu+, and Cu+2), and in turn provide a
foundation for the future rational design of DNAzymes.
To achieve this goal, an array of biochemical and advanced biophysical characterization techniques will be
employed and cross-correlated to determine the locations of metal binding, coordination environments, binding
affinities and specificities, and reaction mechanisms for a series of Fe2+, Fe3+, Cu+, and Cu+2-specific DNAzymes.
Metal-bound DNAzyme resting states will be generated using a series of “non-cleavable” substrates, which will
prove fundamental in determining metal binding affinities, specificities, and key spectroscopic signatures using
UV-Vis/nIR, EPR, and 57Fe Mössbauer spectroscopies. By additionally applying XAS, the rudimentary
coordination environment and electronic structure will be determined. Single point mutations will be screened
across suspected metal-binding regions of oligonucleotide sequences, and the corresponding cleavage
efficiency and characteristic spectroscopic signatures will be tracked to narrow the assignment of metal-binding
site. Further advanced characterization using vibrational and pulse EPR spectroscopies will be used together
with selectively isotope-labeled residues to provide a precise assignment of metal binding location and
coordination environment. All of this information will be matched by computational modeling of first coordination
binding models using a DFT and ab initio approaches. Lastly, a high-risk/high-reward foray will be made to grow
diffraction-quality crystals for holistic structural characterization. Beyond the resting state, the mechanism of
DNA/RNA cleavage by these DNAzymes will be analyzed by a combined analysis of cleaved fragment ends and
careful kinetic characterization. Where necessary, rapid quench flow and rapid freeze quench methods will be
employed to trap and assess potential reaction intermediates.
Achieving the above goals will greatly deepen our understanding of the structure and function of metal-
binding sites in DNAzymes, shifting the paradigm of metalloprotein characterization methodology to include
metallo-DNAzymes. These insights are crucial for rational design and computational modeling to be used
effectively in producing the next generation of metal ion-sensing DNAzymes.

Public health relevance
PROJECT NARRATIVE The ability to trace, distinguish, and quantify different oxidation states of the same redox active metal ion (RAMI) simultaneously in vivo is critical in understanding the labile cellular pool, which a fundamental role in diseases arising from homeostatic imbalances. DNAzymes offer a promising method of accomplishing this, but our current gap in knowledge regarding metal ion-DNAzyme interactions precludes our ability to finely tune their sensing capabilities. This work will make significant contributions to healthcare by improving our fundamental understanding of the interactions of DNAzymes with RAMIs, specifically Fe3+, Fe2+, Cu2+, and Cu+, providing the insight necessary to develop these systems into highly sensitive and selective metal ion sensors.